Vulnerabilities of MMR-deficient glioblastoma

Glioblastoma (GBM) is the most common and lethal brain cancer, with inherent or adaptive resistance to all
existing treatments. One important mechanism by which GBM develops resistance to temozolomide, the
frontline chemotherapy used in its treatment, stems from mutations in genes such as MSH6 and MSH2 critical
in DNA mismatch repair (MMR)—a mechanism found in colon and other cancers as well. These MMR-deficient
GBMs become hypermutated and particularly aggressive as well as resistant to many chemotherapies, and
there is a pressing need to identify therapies that are effective against them. While a recent report describes
two cases of pediatric MMR-deficient, hypermutated GBM that responded to immunotherapeutic checkpoint
inhibitors, our own and others’ clinical experience has uniformly indicated a lack of responses in adult patients
with MMR-deficient, hypermutated GBM treated with these agents. This proposal tests novel therapeutic
approaches to MMR-deficient, hypermutated GBMs and uses unique tools to do so. Our preliminary studies
expand on prior reports suggesting possible activity of calcium channel inhibition against MMR-deficient
cancers to show for the first time that combining inhibitors of different calcium channels—carboxyamidotriazole
(CAI), mibefradil, and verapamil—has preferential and synergistic activity against MMR-deficient GBM lines
versus parental lines. In addition, our preliminary results further suggest TGF-β as a potential target in this
setting, and that the chemotherapy drug irinotecan and the anti-cholesterol statins can be repurposed as TGF-
β inhibitors with preferential activity against MMR-deficient GBM. These therapeutic strategies are being tested
against matched sets of GBM lines that each include a parental line and an MMR-deficient line derived from it,
as well as sets of GBM lines that spontaneously developed MMR deficiency and control GBM lines. The MMR-
deficient lines each have MSH6 or MSH2 insufficiency derived either from mutations secondary to in vivo
temozolomide treatment or from stable expression of shRNA. This proposal will use these matched
parental/MMR-deficient GBM lines to test the effects of calcium channel blockade combinations and TGF-β
inhibition in vitro and in vivo. In addition, given that MMR deficiency and hypermutation and both therapeutic
approaches are likely to impact the anti-GBM immune response, we will also develop an immunocompetent
mouse model of MMR-deficient GBM to test these effects. Both targeted and unbiased studies of mechanism
will be performed, including assessing connections between the two therapeutic strategies and
phosphoproteomic and RNA-seq analyses. The proposed studies will yield new biologic and therapeutic
insights that could rapidly impact the treatment of MMR-deficient, hypermutated GBM and other cancers.

Public health relevance
Glioblastoma is the most common and lethal brain cancer, and one key mechanism by which it develops resistance to chemotherapy involves defects in a DNA repair pathway called mismatch repair (MMR). There are currently no treatments proven to be effective against these especially aggressive MMR-deficient glioblastomas. The work of this proposal investigates two new therapeutic strategies against these cancers: 1) combining inhibitors of different calcium channels, and 2) repurposing the chemotherapy drug irinotecan and the anti- cholesterol statin drugs as novel inhibitors of the TGF-β signaling pathway.